Psychosocial stress, epigenetics and health disparity in hypertension

ABSTRACT
Essential hypertension (EH) remains a significant health problem with striking racial disparity. Compared with
European Americans (EAs), African Americans (AAs) not only have a greater prevalence of EH but also are
specifically prone to the negative effects of EH. Growing evidence indicated that cumulative exposure to
psychosocial stress plays an important role in the development of EH. Racial differences in these social
determinants of EH are likely to contribute to the racial differences in EH. However, little is known about the
underlying molecular mechanisms linking psychosocial stress to early etiology of EH. We hypothesize that
exposure to chronic psychosocial stress adversely affect BP response to acute stress both in laboratory setting
and real life via DNA methylation, impacting the progression of preclinical measurement of EH in early
adulthood and culminating in EH. The fundamental objective of this proposal is to identify these DNA
methylation changes and evaluate whether their roles differ between AAs and EAs. Building on our longitudinal
Georgia Cardiovascular (CV) Twin Study in which a multi-ethnic twin sample of 750 twins (375 twin pairs)
having at least one visit before age 18 and one visit from age 18-26 with blood samples available at this visit,
we will conduct one additional follow-up visit (age range 30-42 years). The longitudinal twin study provides a
powerful design to control both the genetic sources and plastic nature of DNA methylation. The specific aims
are: (1) To examine the joint and distinctive impacts of psychosocial stress on DNA methylation changes in
early adulthood. Genome wide DNA methylation and psychosocial stress exposure will be obtained at age 18-
26 and age 30-42. The CpG sites with their DNA methylation levels associated with stress exposure and
showing changes with changes in exposure will be validated in our Georgia Stress and Heart cohort. Real-time
PCR will also be conducted on genes within ±100kb of these CpG sites to check whether DNA methylation
affects gene expression; (2) To identify the CpG sites with their DNA methylation levels mediating the effect of
psychosocial factors on BP response to laboratory and real-life stress and preclinical measurements of EH
(pulse wave velocity and left ventricular mass); and (3) To test whether the relationship identified in aim 1 and
2 are dependent on ethnicity and whether psychosocial stress related DNA methylation changes can
potentially explain the health disparity between AAs and EAs in the development of EH. Understanding the
underlying biological and molecular mechanisms through which the psychological stress becomes “biologically
embedded” will have the potential to provide new treatment target and lead to effective prevention and
treatment strategies to reduce EH risks in both AAs and communities.

Public health relevance
Project narrative This project aims to find how epigenetic mediates the effect of chronic stress on the risk of essential hypertension and its related racial disparity.